Research Training in Pediatric Non-Malignant Hematology

Project Summary/Abstract
In this T32 renewal application, the Aflac Hematology Training Program (HTP) addresses the crucial need for
programs to train physician scientists and clinical investigators in pediatric non-malignant hematology.
Research in hematology – particularly in pediatrics – has elucidated many of the genetic, cellular and molecular
mechanisms underlying disease processes, as well as fundamental cellular functions such as cell differentiation
and gene regulation. Yet despite the many scientific and clinical advances in hematology over the past decades,
the number of investigators funded by NIH for hematology related research continues to decline. This HTP offers
rigorous training in basic, translational research to postdoctoral MD, MD/PhD and PhD fellows, and in renewal is
expanded to include clinical research training. At Emory University, established research programs in sickle cell
disease, hemostasis and thrombosis, hematopoiesis and stem cell biology, gene therapy, and red cell physiology
and transfusion medicine are embedded in the largest clinical program in pediatric hematology in the country,
providing huge patient volumes for clinical and translational research within Children’s Healthcare of Atlanta.
Partnership with the Georgia Institute of Technology broadens the pool of 34 faculty mentors which includes 21
laboratory researchers and 13 clinical investigators supported by $37.0 M in extramural funding ($14.4 from
Federal sources). Each trainee will have a laboratory and clinical Mentor to foster basic, translational, or clinical
research relevant to pediatric hematology. Pairing of senior mentors with junior mentors from a pool of 14 young
faculty members will expand the supply of future mentors. Integrated into the highly successful Pediatric
Hematology/Oncology/Bone Marrow Transplant (BMT) Fellowship Program of the Aflac Cancer and Blood
Disorders Center, this new HTP has supported 9 trainees over its first 3 ½ years, and in renewal will admit 2
fellows each year for 2 years of support, training 8-10 MD fellows and 2-4 PhD postdoctoral fellows over 5 years.
Candidates will be MD, MD/PhD and PhD fellows within Aflac and associated laboratories, as well as external
candidates chosen for their prior training, academic potential, and commitment to research in non-malignant
hematology. In addition to rigorous laboratory research training, trainees will participate in courses on conduct of
ethical research and enhancing reproducibility, departmental career development seminars, grant writing and
academic skills training, research conferences, journal clubs, and fellowship program research retreats. Individual
Training Plans will be developed for each trainee and progress will be monitored by multidisciplinary scholarship
oversight committees. Trainees will present their work locally and at national meetings and develop applications
for career development (K-type) awards. The HTP leverages the extensive research resources of Emory
University, including formal course work and degree programs in clinical and translational research available
through Emory’s CTSA program. Renewal of this T32 will contribute to training the next generation of academic
leaders in pediatric non-malignant hematology.

Public health relevance
Project Narrative Research in hematology has yield important knowledge about fundamental biological processes and has improved the survival and quality of life for persons with blood diseases. Great strides have been made in the treatment of children with sickle cell disease, hemophilia, bone marrow failure and other blood disorders. Yet the number of well-trained researchers in this field is steadily declining, especially in pediatrics. This T32 Training Grant is designed to address this problem by providing high quality research training to highly motivated and talented post-doctoral MD, MD/PhD, and PhD researchers to enable them to become the next generation of physician scientists and translational investigators in pediatric non-malignant hematology.